Evaluating DR2 agonism as a potential therapeutic approach to substance abuse and traumatic brain injury

Title: Evaluating DR2 agonism as a potential therapeutic approach to substance abuse
and traumatic brain injury
Abstract
Substance use disorder (SUD) and traumatic brain injury (TBI) are inextricably and
bidirectionally linked. SUD is one of the strongest predictors of TBI, and a substantial
proportion of TBIs occur in addicted individuals. An inverse relationship is also
emerging, such that TBI can serve as a risk factor for, or modulate the course of, SUD.
Critically, substance use after TBI is a key predictor of rehabilitation outcomes,
prognosis, and additional head injuries. Currently, there are no FDA-approved treatment
options for either TBI or SUDs associated with psychostimulants. DR2 agonism has
potentially reemerged as a potential therapeutic approach under both conditions
because of their relatively low abuse liability profile. Using a translational approach, the
objective of this application is to explore the therapeutic potential of DR2 agonism in
TBI and substance use. This application will seek to answer these research questions:
1) Does DR2 mitigate the neuroinflammatory state associated with TBI and substance
use and 2) Does D2 agonism influence the proteogenomic relationship in either TBI
and/or SUDs. The objective of this application will be accomplished by addressing the
following: Aim 1: Determine the neuroprotective potential of dopaminergic agonists in
an in vitro ischemic/substance use model of the neurovascular unit and Aim 2: Define
the proteogenomic profiles of D2 agonism on TBI/SUD protein expression by cutting-
edge RNA-seq and proteomics. This study is innovative because it employs a novel,
dynamic blood-brain barrier platform capable of recapitulating human in vivo
physiological parameters. This study is significant because it will highlight specific
signaling and gene expression profiles associated with TBI, and substance use to
develop specific treatment endpoints The long-term goal of this is to develop data for
further proposal preparation and to identify new molecular targets for further
therapeutic development.

Public health relevance
Project Narrative Our study aims to evaluate the therapeutic potential of Dopamine Receptor 2 (D2R) agonists in reducing neuroinflammation and improving BBB integrity following TBI and substance abuse. Utilizing a novel in vitro blood-brain barrier model, we will address one of the NIDA 2022-2026 mission goals of exploring pharmacological agents to treat substance use by evaluating the effects of D2R agonists, such as quinpirole, on microvascular integrity and inflammatory responses. By studying how these agonists modulate both methamphetamine-induced neurotoxicity and TBI-induced secondary injuries, we aim to identify new therapeutic strategies to improve outcomes for individuals suffering from these co-occurring conditions through a proteogenomic approach.